Regulation of Temporal and Spatial Gene Expression in the Circadian System

Our Unit is interested in the molecular mechanisms underlying regulated patterns of gene expression, both in time and space. During FY 99 we have identified and characterized a functional E-BOX cis-acting element in the promoter region of the rat Arylalkylamine N-acetyltransferase (NAT) promoter that can mediate transactivation by the circadian complex CLOCK/bMAL apparently only in the retina (a master oscillator) but not in the pineal (slave oscillator). We are also continuing our efforts to identify the critical elements that constitute a circadian E-BOX by comparing the cyclin, NAT and vasopressin (AVP) E-BOXES which support different levels of transactivation by the circadian transcription complex CLOCK/bMAL (0, 8 and 40- fold increase respectively).In addition, we have successfully used the NAT promoter to drive a dominant negative form of the Fra-2 transcription factor to the rat pineal gland through a collaborative transgenesis program. This achievement has enabled us to identify the first Fra-2 target genes in vivo: Fra-2, type II deiodinase, Nectadrin (or CD24) and Id-1 (a basic- HLH class transcription factor). A second project is derived from our discovery during FY 99 of a novel gene, by a yeast two hybrid system, that interacts specifically with Period (Per) 1, one of the core components of the cellular machinery that generates the self-sustained 24 hr cycle in transcriptional output. We are currently characterizing this novel gene and its interaction with Per 1, as well as its tissue distribution and function(s). A knockout approach is also underway.